Effect of allergic asthma on CD8+ TRM-mediated protection from infection

Individuals suffering from local Th2-type inflammatory diseases, including allergic asthma have increased risk
for serious viral infections, but the cause is unclear. Defense against local infections relies on tissue
resident memory CD8+ T cells (TRM) that reside within peripheral tissues and deliver rapid defense against
pathogens and tumors. Following antigen challenge, CD8+ TRM secrete cytokines that activate innate cells,
induce expression of anti-viral and anti-bacterial genes, and recruit circulating leukocytes for pathogen control.
Given their central role in host protection, we hypothesize that impairment of CD8+ TRM contributes to severe
infection in patients with atopic diseases. Our preliminary data demonstrate that IL-4 uniquely prevents TGF--
induced expression of the adhesion receptors CD49a and CD103 that are required for CD8+ TRM persistence
within peripheral tissues. In parallel, in vivo studies reveal that exposure of CD8+ T cells to IL-4 decreases both
their expression of CD103 as well as their accumulation within skin. Based on these preliminary data, we
propose to extend these studies using a mouse model of allergic asthma to test the novel hypothesis that Th2
cytokines impair lung CD8+ TRM formation, persistence and defense against respiratory infection. Specifically,
we propose to: 1) Determine the impact of a Th2-type microenvironment on lung CD8+ TRM
formation/persistence, as well as on the phenotypic stability of established CD8+ TRM; and 2) Determine the
consequence of IL-4 on lung CD8+ TRM-mediated protective immunity to influenza infection.

Public health relevance
Individuals suffering from allergic asthma are at increased risk of developing severe infections, but the reason(s) are not well understood. Our goal is to determine whether the local lung environment in patients with allergic diseases impairs immune cell-mediated protection from infection. Based on these studies, novel therapies may be developed to improve protective immunity in these patients.